Integrative Cell Phenotyping Core

Abstract – Integrative Cell Phenotyping Core (ICPC)
Several cell types are involved in inflammatory processes in rheumatic diseases. Understanding the
pathobiology of these diseases often requires dissecting out contributions of specific cell subpopulations. The
ICPC (Integrative Cell Phenotyping Core) will provide technical expertise, assistance and equipment at a
reasonable cost to investigators in the Cincinnati Rheumatic Disease Core Center (CRDCC) whose studies
require single cell analysis. ICPC provides training in proper use and interpretation of a number of
immunophenotyping methodologies, including flow cytometry, multiplex analyte analysis and single cell
genomic, proteomic and spatial transcriptomic analysis. Expertise and assistance will be provided by Core
personnel in the following areas:
• High-parameter immunophenotyping (cell surface and intracellular)
• Single cell gene expression analysis
• Cell sorting
• Gene expression reporter analysis
• Cell proliferation analysis
• Cell cycle and DNA content analysis
• Apoptosis analysis
• Intracellular calcium mobilization analysis
• Tetramer staining of antigen-specific T cells
• RNA detection by flow cytometry
• Cell signalling analysis
• CRISPR genome-edited cell identification and sorting
• Imaging cytometry
• Multiplex protein/analyte detection
• Single cell protein secretion
• Spatial transcriptomics
In addition, the ICPC will facilitate acquisition, analysis and storage of immunophenotyping data, maintain
standards and quality control for immunophenotyping, single cell gene expression, and spatial transcriptomics
procedures, and will assist in the application and development of new techniques.